Defining STING Interactions that are Required for Rhinovirus Replication

ABSTRACT
Rhinoviruses (RVs) are responsible for the majority of upper respiratory tract infections in humans yearly.
Recently, several reports, including one from our lab, have identified stimulator of interferon genes (STING) as
a pro-viral factor during RV replication. Still, the STING-mediated interactions and associated function(s) that are
required for robust RV replication remain unknown. Current data suggest that STING traffics to membranous
structures called replication organelles (ROs) during RV infection. RO formation is orchestrated by virus-
mediated manipulation of host proteins, cellular membranes, and lipid metabolism pathways and the resulting
lipid composition of ROs is both unique and critical for efficient RV replication. Elevated phosphatidylinositol 4-
phosphate (PI4P) levels, for example, are a hallmark of RV ROs and PI4P synthesis at sites of viral replication
requires RV to recruit PI4-kinase beta (PI4Kβ). Notably, recent work investigating STING function has described
an interaction between STING and PI4Kβ through Armadillo Like Helical Domain Containing 3 (ARMH3). These
data suggest RV may utilize STING to nucleate a PI4Kβ-containing complex and/or link key host factors to
promote PI4P enrichment at the site of replication. Additional new data has revealed STING as a regulator of
lipid metabolism and have shown STING to promote lipid peroxidation and ferroptosis. This is important since
lipid peroxidation has significant impacts on viral replication and is pro-viral for other enteroviruses. Taken
together, we propose a model whereby STING translocation to ROs 1) promotes STING–ARMH3 interaction,
thereby facilitating PI4P enrichment at the site of RV replication and 2) alters STING interaction with fatty acid
synthesis pathways, tipping fatty acid synthesis towards the production of polyunsaturated fatty acids and driving
increases in lipid peroxidation which further support efficient viral replication. Thus, the aims of this grant will test
the hypothesis that STING is required during RV infection to establish the proper lipid environment for viral
replication through multiple pathways and further capture novel STING partners during RV infection through
unbiased screening. Successful completion of these aims will further define the mechanism underlying the pro-
viral role of STING during RV infection and provide novel insights into evolutionarily conserved functions of
STING which maintain homeostasis in mammalian cells. Such advances will facilitate the design of therapeutics
against rhinovirus and multiple degenerative diseases in which the cGAS-STING pathway is involved.

Public health relevance
PROJECT NARRATIVE Rhinoviruses (RVs) are responsible for the majority of upper respiratory tract infections in humans yearly. Recently, work from our group and that of others has demonstrated a pro-viral role for stimulator of interferon genes (STING) during rhinovirus replication; however, the STING-mediated interactions and associated function(s) that are required for robust RV replication remain unknown. Through our proposed aims we will define STING interactions and interrogate a potential role for STING in facilitating phosphatidylinositol 4-phosphate (PI4P) enrichment and regulating fatty acid synthesis during RV replication organelle formation, yielding novel insight into virus-host interactions and indicating new therapeutic targets.